Aberrant remodeling of bladder following infection

Since a major complication of UTIs is frequent recurrence, there appears to be a fateful defect
in the urinary immune system. A distinct feature of the bladder which appears to contribute to
their susceptibility to reinfection is the high degree of atypical tissue remodeling that occurs
following each infection, predisposing the bladder to future infections. Since very little is
currently known regarding bladder remodeling, studies on this topic may reveal new strategies
to combat recurrent UTIs. We have hypothesized that because of the highly cytotoxic and
hyperosmolar nature of urine, the bladder initiates a vigorous re-­epithelization and remodeling
program to rapidly recover lost epithelium after each infection. Our preliminary studies have
validated this notion and revealed that T cells recruited into the bladder are more specialized in
directing tissue repair (Th2) than in pathogen elimination (Th1). Consequently, the infecting
bacteria in the bladder are not completely eliminated following resolution of infection,
predisposing this organ to future flare-­ups. Since the tissue repair T cells recruited into the
bladder tend to persist and could be quickly evoked with reinfection, the magnitude of the
remodeling program is high, significantly impacting bladder voiding capacity. We have found
that a critical immune regulator associated with the bladder repair program is a distinct subclass
of dendritic cells (DCs), which moves into the subepithelial region of the bladder soon after the
loss of the superficial epithelium. Here, we propose to determine the specific role of this DC
subclass in epithelial repair. We will also examine the underlying basis for the Th2 bias of T
cells recruited into the bladder following bouts of infection. Finally, we will investigate the
possibility of reprograming Th2 primed bladder response into a Th1 type response by
immunizing naïve and chronically infected mice with a vaccine antigen co-­administered with Th1
biasing adjuvant. We suspect that such vaccines will not only protect bladder from future
infection but also permit recovery of bladder function in these mice

Public health relevance
Relevance Statement: A distinct feature of the bladder is its increased susceptibility to reinfection which appears to grow with each infection. We have attributed this phenomenon to preferential recruitment into the bladder of cells specialized in tissue repair over cells that are capable of eliminating pathogens, which leaves this organ prone to reinfection. Our goal here is to examine the basis for this aberrant response and to device a preventive vaccination strategy.